Supporting the implementation of prevention strategies by public health nurses to reduce intimate partner violence in Alaska

PROJECT SUMMARY/ABSTRACT
Intimate partner violence (IPV) is a critical social determinant of health, affecting over 40% of women and men
in the US. IPV is particularly prevalent in Alaska and disproportionately impacts American Indian and Alaska
Native individuals. Given the widespread prevalence, impact on marginalized communities, and associated
adverse outcomes, prevention strategies are urgently needed. Public health nurses (PHNs) can play a key role
in IPV prevention, particularly in rural and underserved communities. These nurses work “upstream” to prevent
and mitigate risks for underlying social determinants of health and have unique skills in communication,
collaboration, promoting health equity, and applying evidence-informed approaches. Alaska has a unique
geography and largely centralized public health system with a statewide infrastructure to deploy prevention
practices. In their 2018-2021 strategic plan, Alaska’s statewide Section of PHN, within their Department of
Health, made IPV a priority focus area. During the COVID-19 pandemic, the PHN strategic plan lapsed as their
focus shifted to infection control, even as IPV grew in Alaska. The Alaska Section of PHN is now recentering
their prevention efforts and updating their strategic plan. To guide their strategic planning process, we propose
a practice-based research partnership between academic researchers at two leading research institutions and
Alaska’s statewide Section of PHN to advance the use of high-impact, evidence-informed IPV prevention
practices throughout the state. With input from Advisory Board members representing diverse organizations in
Alaska, a team of interdisciplinary researchers and practitioners with expertise in IPV prevention, public health
systems, practice-based research, mixed methods, and implementation science will initiate an Implementation
Mapping process that combines quantitative data from existing sources (i.e., administrative data documenting
PHN activities across the state) with newly acquired qualitative data from focus groups with PHNs and other
state public health leaders. Specifically, we will: (1) describe the array of IPV practices delivered by PHNs
throughout the state; (2) identify barriers to and facilitators of effective implementation of IPV practices
delivered by PHNs; and (3) develop implementation strategies for PHNs to overcome common barriers to
effective implementation of evidence-informed IPV practices using established implementation science
frameworks: RE-AIM (Reach, Effectiveness, Adoption, Implementation, Maintenance) and the Consolidated
Framework for Implementation Science (CFIR). This project is closely aligned with the Social Determinants of
Health and Health Equity research lenses of the National Institute of Nursing Research. Identifying and
implementing IPV prevention practices that are evidence-informed, feasible, culturally relevant, and
contextually appropriate is critical to the advancement of IPV prevention led by PHNs in Alaska. Findings will
benefit state and national organizations engaged in IPV prevention with rural and underserved communities
and support further research regarding IPV prevention and PHN practice.

Public health relevance
PROJECT NARRATIVE Intimate partner violence (IPV) is widespread in Alaska, and public health nurses play an important role in prevention, particularly in rural and underserved communities. The proposed study will leverage a practice- based research partnership with Alaska’s statewide Section of Public Health Nursing to advance the use of evidence-informed IPV prevention practices throughout the state by describing IPV practices delivered by public health nurses, identifying barriers to and facilitators of implementing IPV practices by public health nurses, and developing strategies for public health nurses to implement evidence-informed IPV practices. Findings will provide actionable information for local and state public health staff and leaders in Alaska, as well as other state and national organizations engaged in IPV prevention with rural and underserved communities.